Mechanisms for the repair of oxidative stress-induced DNA damage in Porphyromonas

Porphyromonas gingivalis, as a “keystone pathogen”, highlights its ability to adapt to the harsh inflammatory
conditions of the periodontal pocket. Because the environmental stress response is a major determinant of its
virulence, it is our long-term goal to gain a comprehensive understanding of its survival strategy(s). DNA
damage is a major consequence of oxidative stress. While more than 20 different oxidatively altered bases
might be generated by this stress, 8-oxo-7,8-dihydroguanine (8-oxoG) is one of the most common product of
DNA damage. Guanine is the most susceptible base to oxidation and forms mainly 8-oxoG due to its low redox
potential. In prokaryotic cells the presence of 8-oxoG is mainly repaired by base excision repair (BER). A
survey of the P. gingivalis genome indicate that an important component of the BER system is missing. Because
the average G + C content of the genome of P. gingivalis is 49%, a mechanism(s) to prevent or repair lesions
resulting from guanine oxidation is vital. There is a gap in our comprehensive knowledge on a mechanism(s) for
the repair of oxidative stress-induced DNA damage in P. gingivalis. We have previously demonstrated that there
is an accumulation of 8-oxoG in the chromosome of P. gingivalis exposed to H2O2-induced oxidative stress.
Neither BER nor nucleotide excision repair (NER), as observed in other strains, appear to be involved in the
repair of the 8-oxoG lesion in P. gingivalis. DNA affinity fractionation identified PG1037, a conserved hypothetical
protein, among others, that were preferentially bound to the oligonucleotide fragment carrying the 8-oxo-G lesion.
PG1037 is part of the uvrA-pg1037-pcrA operon in P. gingivalis which is known to be upregulated under H2O2-
induced stress. The purified recombinant PG1037 protein, likely via a reducing function, has the ability to prevent
Fenton chemistry-mediated DNA damage in vitro and, under oxidative stress conditions, reduced the cleavage
of the 8-oxoG lesion by the E.coli foramidopyrimidine glycosylase (Fpg) enzyme. In silico analysis of PG1037
shows a protein that contains a zinc finger domain, two peroxidase homologous motifs and a cytidylate kinase
domain. The goal of the proposal is to test the hypothesis that a novel P. gingivalis protein (PG1037)
carrying peroxidase motifs and a zinc finger domain is involved in the repair of oxidatively damaged
DNA. Our aims are to confirm the specific role of PG1037 in the removal of 8-oxoG from duplex DNA and to
evaluate any interaction of PG1037 with other proteins in that process. The data will provide a major conceptual
advance on the molecular bases for the repair of oxidative stress-induced DNA damage in P. gingivalis and
could likely support a unique and effective DNA repair mechanism we propose to designate “base redox repair”.
It will set the stage, in a future RO1 application, to address specific structure-function questions on the vital
components and their corporation in maintaining genomic stability in anaerobes exposed to environmental
stress. These components could be targets for the development of novel therapeutic interventions for the control
and prevention of P. gingivalis-associated diseases.

Public health relevance
PROJECT NARRATIVE The goal of this research is to characterize newly discovered important factors that will facilitate the survival of the periodontal pathogen Porphyromonas gingivalis in the inflammatory environment of the periodontal pocket. Because this environment may cause severe damage to the organism and given its success as important cause of gum disease suggests that P. gingivalis has properties that will facilitate its ability live in a stress environment. Important factors that are essential for survival are prime targets for the development of novel therapeutics that will have a positive impact on human health.